Neural representation of mating partners by male C. elegans

Project Summary
Understanding how neural circuits create animal behavior requires knowing the system-wide activity patterns
that connect sensory experience to motor activities, all within the full set of feedback loops by which actuated
motor decisions modulate the animal's perceptions of itself and the outside world during naturally executed and
unrestrained behaviors. Mechanistic understanding further requires interpretation of system-wide activity
patterns in terms of the connectivity, synaptic, and cellular properties of all relevant neurons. Modeling requires
comprehensive mapping of the salient dimensions of sensory input and motor output, as well as how high-
dimensional neural activity patterns are properly projected, by decision-making and the internal constraints of
the nervous system and motor system, into the fewer dimensions that characterize any animal's observed
behavior. Such models are facilitated by using animals where entire brain and motor circuits can be mapped and
interrogated with full molecular and cellular resolution. Here, we will use the mating behavior of the male C.
elegans as such a paradigm. The mating behavior of C. elegans is a critically important and goal-directed task
that occurs in natural environments and is robustly executed in the laboratory. Males use a specialized circuit of
~100 neurons – sensory neurons, interneurons, neuromodulatory, and motor neurons – all contained within the
male tail ganglia to locate hermaphrodites, locate the vulva along the hermaphrodite's body, and initiate and
complete insemination. A diverse set of mechanosensory, chemosensory, and pheromone sensing neurons are
used to recognize the shape, texture, and chemical signature of the hermaphrodite body. Several neurons are
specialized to detect fiducial points along the hermaphrodite body. The male implicitly uses an internal
representation of the size, shape, and predictable behaviors of the hermaphrodite to positively recognize the
hermaphrodite, infer its own position along the hermaphrodite, and execute an optimal movement strategy to
maintain contact with the hermaphrodite and find and penetrate the vulva. It is now possible to record neural
activity from the entire set of neurons in the male tail with high temporal resolution and complete cellular
resolution. We will couple experiments, modern data analysis and modeling methods, and cellular and molecular
genetic perturbations to elucidate the full set of sensorimotor events that organize the mating behavior. We will
develop a realistic model of the circuit that integrates the observable behavioral algorithms with the connectivity
and activity patterns of the male tail ganglion. We will apply genetic tools to identify and elucidate each sensory
neuron type, and how it affects each aspect of decision-making by downstream interneurons and motor neurons.
We will characterize key synaptic properties by molecular dissection of neurotransmitter and receptor types. We
will store this comprehensive neurophysiological and neurogenetic data in online project databases connected
to our computational models that will allow the wider community to view and probe our data-driven modeling
eff ort.

Public health relevance
Project Narrative Understanding the function of neural circuits depends on knowledge of neural connectivity and activity in response to ethologically-relevant stimuli. The Caenorhabditis elegans male connectome is known and the complete neural circuit can be imaged in freely moving, behaving animals. These features, coupled with computational modeling and cell specific perturbations will allow us to analyze how the male nervous system represents its mating partner during key aspects of sexual behavior.